Evaluations of Increasing State Investments in Primary Care: Effects on Health Care Spending, Utilization, and Quality

Primary care accounts for only 2-7% of U.S. health care spending across payer populations, leading to an
underfunded primary care delivery system. In response, states are increasingly adopting policies to increase
spending on primary care, with the goal to improve prevention, chronic disease management, and slow the
growth of total health care spending.1-5 To date, 4 leading states—Rhode Island, Oregon, Delaware, and
Colorado—have enacted legislation or regulations to increase primary care spending, generally by requiring
private insurers to explicitly raise the percentage of health care spending spent on primary care.
Despite the importance of these state efforts to invest in primary care, their effects on total spending, health
care utilization, and quality of care remain largely unknown. This dearth of rigorous evidence is increasingly
relevant, as additional states (including California, Maine, Massachusetts, and Pennsylvania) are now debating
or designing similar legislation to increase primary care spending. To address this gap in knowledge, we will
conduct rigorous quasi-experimental evaluations, using newer matching techniques to improve causal
inference, of the Rhode Island, Oregon, Delaware, and Colorado models to raise primary care spending.
The initial evaluation of the Rhode Island model, conducted by our team, focused on the model’s short-run
effects on commercial insurer spending. We found that Rhode Island’s commercial spending decreased by 9%
relative to enrollees from other states, with this reduction driven by the caps on hospital prices in the initial 4-6
years. However, as Rhode Island continues to sustain its primary care investments and other states look to do
the same, long-run evidence on the policy’s effect is absent. Moreover, knowledge of its effects on quality
of care, use of high and low value care, and spillovers in Medicare and Medicaid patients remains lacking.
This project builds on our earlier work in four key ways. First, using large public and private claims data, we
will investigate changes in spending, utilization, and quality (both within and outside of primary care)
associated with the Oregon, Delaware, and Colorado models—all of which have been enacted. Oregon’s
legislation aims to raise primary care spending to 12% of total spending starting in 2023. Delaware’s model,
effective 2021, increases primary care spending by 1-1.5 percentage points each year until 2025. Colorado’s
model similarly increases primary care spending by 1 percentage point each year through 2023. Second, we
will extend our Rhode Island evaluation through a decade following the policy, with the key addition of
utilization and quality outcomes. Because it took a few years for the delivery system to respond, as our first
study showed, potentially important long-run effects have yet to be evaluated. Third, we use newer statistical
methods in matching and weighting within a quasi-experimental design to better isolate the policy effects.
Lastly, in all 4 states, we will assess spillover effects of their primary care investment across payers—into
the Medicare and Medicaid populations—which is important for both states and the federal government.

Public health relevance
Project Narrative Given that only 2-7% of U.S. health care spending is devoted to primary care, a chronically underfunded but foundational part of the delivery system, states across the country are increasingly adopting policies to increase primary care spending, hoping to slow total spending and improve the quality of care. Four states— Colorado, Delaware, Oregon, and Rhode Island—have enacted legislation or regulations to explicitly raise the percent of health care spending spent on primary care, but the effects of these models on primary care access and continuity, total health care spending, utilization (in and outside of primary care), and quality of care remain largely unknown. This gap in knowledge is increasingly detrimental as many additional states are now debating or designing similar legislation to increase primary care spending; this project addresses this key gap through rigorous quasi-experimental evaluations of the Colorado, Delaware, Oregon, and Rhode Island models, using newer statistical methodology in matching and weighting to improve causal inference.